Functional Analysis of the Ribosome CAR Surface

PROJECT SUMMARY/ABSTRACT
Gene expression is controlled at multiple levels that are integrated so that cells, tissues and organisms can
respond efficiently and quickly to changing environments. Regulated transcription of mRNAs is followed by
integrated mechanisms of translational control to determine levels of protein production. Our proposed
research is aimed at investigating a layer of translational regulation that depends upon a newly-identified
ribosome interaction surface that is anchored to the ribosome A-site decoding center, allowing it to H-bond with
the +1 codon that is next to enter the A site. This “CAR” interaction surface consists of three conserved
residues—16S/18S rRNA C1054, A1196 (E. coli numbering) and ribosomal protein S3 R146 (S. cerevisiae
numbering; conserved in eukaryotes)—and is anchored at the beginning of translocation to tRNA nucleotide
(nt) 34, the anticodon partner of the codon wobble nucleotide. The CAR surface has the interesting property
that its interactions are strongest when the +1 codon conforms to a GCN sequence. Since the initial codons—
the ramp region—of a gene’s ORF are particularly influential in determining the rate at which ribosomes are
launched down the mRNA, the extent to which ramp regions conform to GCN codons likely determines the
sensitivity of each gene to this layer of regulation.
An emerging idea in ribosome biology is that different versions of ribosomes are made under various cellular
conditions, allowing cells to regulate protein translation according to their environments. Our analysis suggests
that whether newly made ribosomes have modifications of various residues in the decoding center
neighborhood—R146, one of the CAR residues, as well as several rRNA nucleotides—may determine whether
the CAR interface can interact with the +1 codon. The enzymes for these modifications are down-regulated
under stress conditions, and our molecular dynamics analysis indicates that when these modifications are
present, the interaction of CAR with the +1 codon is considerably weaker. We will test if modification levels are
reduced under stress in Aim 1. We also plan to examine ribosome behavior on mRNAs under stressed and
unstressed conditions using ribosome profiling experiments to assess whether interactions between CAR and
the +1 GCN codons may influence the rates at which ribosomes travel along the mRNA during translation (Aim
2). Since tRNA nt 34, which anchors CAR to the tRNA anticodon, often contains various modifications that are
stress-dependent, we will carry out molecular dynamics analysis to test whether these modifications change
anchoring of CAR to the anticodon with consequent changes in interactions of CAR with the +1 codon (Aim 3).
This project, with its focus on integration of in vivo testing and computational modeling of ribosome dynamics, if
successful, will lead to important insights into a new layer of translational regulation, and provide students with
in-depth introductions to analysis of a system at the molecular level, as well as interdisciplinary modes of
inquiry that reveal underlying behaviors of this biologically important system.

Public health relevance
PROJECT NARRATIVE Using in vivo and computational experiments, we are investigating a core question in biology: how cells tune protein translation levels in response to different cell environments such as stress. We are identifying the molecular mechanisms by which mRNAs with GCN-enriched ramp regions are recognized by the ribosome CAR interaction surface, and how this may sensitize these genes to translational regulation by ribosomes made under stress with altered residue modifications in their decoding center.